The Aging Pancreas as a Pro-tumorigenic Niche

PROJECT SUMMARY
Age is a major risk factor for pancreatic ductal adenocarcinoma (PDAC), with the incidence of PDAC rising
sharply with increasing age. Most PDAC cases occur in individuals who are over the age of 60, and the risk
continues to increase with each decade of life. The median age at diagnosis and death for PDAC is around 70
and 72 years old, respectively. Although PDAC can occur at any age, it is relatively rare in younger individuals,
and it is uncommon for people under the age of 40 to develop PDAC. It is not clear why age is a significant risk
factor for PDAC but like other age-associated cancers there are likely multiple variables at play. Like other
diseases, we use sophisticated mouse models to study PDAC, but none have been used to address the impact
of aging on disease initiation or progression. This proposal is based on our preliminary data demonstrating that
PDAC progression is accelerated in old animals. We have found that increased organismal age significantly
enhances the growth of primary PDAC tumors and increases metastasis. Remarkably, we find that the immune
landscape is vastly different in tumors generated in young versus old animals, and that intratumoral desmoplasia
is heightened with age. Our findings are in line with the established prominence and importance of the PDAC
tumor stroma in tumor progression and suggest that aging substantially affects the functional characteristics of
the stromal cells. Most of the stromal cells within a PDAC tumor are cancer-associated fibroblasts (CAFs) and
how the functionality of these CAFs changes with age is totally unexplored. Moreover, whether other aspects of
PDAC biology, such as tumor initiation, are affected by age remains an unanswered question. Based on our
preliminary data, our central hypothesis is that age plays a critical role in PDAC by accelerating tumor initiation
and progression. In this proposal, we will 1) examine the influence of the aging stroma on tumor growth and
progression, and 2) investigate the impact of age on the intrinsic oncogenic potential of the pancreas. This project
will be of great significance, novelty, and impact, as it will constitute the first evaluation of the impact of aging on
PDAC initiation and progression. Our work will establish new paradigms for the study of PDAC, and will set the
framework for evaluating potential PDAC therapies from a patient-centric perspective.

Public health relevance
PROJECT NARRATIVE Age is a major risk factor for pancreatic ductal adenocarcinoma (PDAC) with the median age at diagnosis and death being around 70 and 72 years old, respectively. It is not clear why PDAC is a disease of aging, but like other age-associated pathologies there are likely multiple variables at play. Using our preliminary data as a launching point, in this application we will develop new experimental models and decipher the mechanisms of how aging accelerates PDAC initiation and progression.